Microscopy and Imaging Module

PROJECT SUMMARY - MICROSCOPY
For over 40 years, the Microscopy and Imaging Core Facility (MICF) has been a module in the
Wilmer P30 Core Grant, evolving from providing transmission and scanning electron microscopy to
providing diverse, state of the art equipment to vision scientists and their collaborators. Our
community of researchers includes nearly 180 hands on users. The Department of Ophthalmology’s
Smith Building houses the MICF, allowing convenient access to confocal, multiphoton, electron
microscopy, high throughput screening, fluorescent activated cell sorting (FACS) and histological
equipment to these investigators. Having these resources housed within one location, easily
accessible to all, has resulted in a highly productive and collaborative research program, as
demonstrated by the extensive number of NIH-funded projects and publications this Core has
supported: over 175 publications during the past five years, of which 50% are collaborations between
investigators. The personnel supported by this module have a combined 70 years’ experience in eye
research, providing equipment training and maintenance, consultation on experimental design and
frequently develop new methodologies in collaboration with the facility users.